The Role of Local Microcircuits in Shaping Sensory Cortical Activity and Perception

PROJECT SUMMARY / ABSTRACT
Cortical dysfunction has been implicated in many neurological disorders including epilepsy, schizophrenia, and
stroke. The majority of cortical connections are local, implying that local microcircuitry should be a dominant
contributor to pyramidal neuron receptive fields and, therefore, perception. Cortical microcircuit motifs include
recurrent excitation and inhibition, which mediate interactions between similarly tuned populations, and feed-
forward excitation and lateral inhibition, which mediate interactions between distinctly tuned populations.
Studying these motifs in vivo has proven challenging because pyramidal neurons with different functional
tuning are often intermingled, requiring cellular-resolution perturbation approaches to probe microcircuit
function. The objective of this proposal is to test the hypothesis that local microcircuit interactions shape neural
receptive fields during naturalistic behavior, and that these interactions contribute to perception. We focus on
mouse primary vibrissal somatosensory cortex (vS1), where sensory input from single whiskers outputs onto
small patches of cortex known as `barrels', making individual whisker sensory representations tractable targets
to comprehensive recording and subsequent perturbation. In previously published work, we demonstrated the
ability to record and classify the majority of layer (L) 2/3 neurons in a barrel. Here, we present preliminary data
demonstrating the ability to lesion small subsets of identified neurons in a barrel using multiphoton ablation,
thereby overcoming the previous constraint on experiments probing the role of recurrent amplification among
similarly tuned neurons. Preliminary experiments in single-whisker mice indicate that recurrent excitation in vS1
L2/3 amplifies the responses of neurons tuned to whisker touch, but not of those tuned to whisker movement,
and that recurrent inhibition does not exert a measurable effect on touch responses. Further preliminary data
in mice with two whiskers reveals that feed-forward excitation from single-whisker responsive neurons shapes
multi-whisker responses and that cross-whisker suppression declines following single-whisker neuron lesions.
Finally, preliminary barrel-scale lesion experiments reconcile recent controversies in the field and show that
vS1 is necessary for discrimination but not detection behaviors. We propose three aims testing 1) whether
recurrent interactions – excitatory and inhibitory – shape vS1 L2/3 responses of neurons tuned to the same
whisker; 2) whether L2/3 excitatory touch neurons tuned to different whiskers interact via feed-forward
excitation to generate multi-whisker receptive fields and via lateral inhibition to produce cross-whisker
suppression; 3) whether individual vS1 barrels contribute to perception, and whether L2/3 recurrent excitation
in vS1 contributes to perception. The proposed work involves a novel combination of large-scale two-photon
calcium imaging, multiphoton ablation, barrel-scale lesions, and quantitative head-fixed mouse behavior. Our
long-term goal is to understand sensory microcircuit computations and how they shape perception.

Public health relevance
PROJECT NARRATIVE Cortical diseases, including schizophrenia, epilepsy, and stroke, exert a tragic cost on millions of Americans and have a large impact on public health. This project aims to expand our understanding of the physiological underpinnings of cortical receptive fields and their behavioral role by examining the circuit mechanisms that give rise to them. Through cellular-resolution lesions combined with large-scale activity recording via two- photon calcium imaging, this project asks how interactions between groups of similarly and distinctly tuned sensory neurons shape receptive fields and contribute to perception. !